Ins and outs of the bioactive sphingolipid metabolite sphingosine-1-phosphate

PROJECT SUMMARY AND RELEVANCE
The sphingolipid metabolites, sphingosine-1-phosphate (S1P) and its precursors sphingosine and ceramides,
have emerged as pleiotropic signaling molecules that regulate diverse cellular responses. Previously, we have
shown that in response to numerous stimuli, S1P produced intracellularly by two sphingosine kinases, SPHK1
and SPHK2, is exported out of cells via a specific transporter Spinster homolog 2 (SPNS2) to activate its
receptors S1PRs. While this process that we coined “inside-out signaling by S1P” is responsible for many of its
known functions, it has long been suspected that SPHK and the sphingolipids it regulates, S1P, sphingosine,
and ceramide, also have intracellular functions. This is an important gap that our research and the MIRA
proposal are aimed at filling as lower organisms express the evolutionary conserved sphingolipid metabolic
enzymes and although sphingolipid metabolites regulate important biological functions in these organisms,
they do not have S1PRs. Moreover, these enzymes are present in distinct subcellular compartments,
suggesting that the location(s) where sphingolipid metabolites are produced dictates their functions. The MIRA
proposal is focused on the roles of these sphingolipid metabolites in governing membrane contact sites (MCS)
between the ER network and late endocytic organelles versus the plasma membrane to control the movement
of cholesterol and sphingolipids between distinct cell membranes and their metabolism. Our research will also
address the involvement of these sphingolipid metabolites in establishment of lysosome-mitochondria MCS
and consequence to mitochondrial function and bioenergetics and define how they regulate localization of
GRAMD1s family, evolutionarily conserved ER-anchored cholesterol transfer proteins. Another goal of the
proposed research is to understand the functional transport mechanism of SPNS2, which remains
controversial, and could have important ramifications as SPNS2 has been linked to metabolism, cancer
metastasis, and auditory, inflammatory, and immune disorders.
The new conceptual groundwork in this proposal will alter our understanding of sphingolipid metabolites
signaling and will reveal their ancient but understudied intracellular roles in regulation of membrane dynamics
and contact sites as sensors that integrate and coordinate sphingolipid and cholesterol metabolism, and
potentially glucose homeostasis. Although this area of research is just in its infancy, we believe that our
proposed studies will shed new light on enigmatic functions of bioactive sphingolipids appropriate to their name
associated with the riddle of the Sphinx. It should also provide deeper understanding of how perturbations of
these fundamental biological processes contribute to human diseases.

Public health relevance
PROJECT NARRATIVE The sphingolipid metabolites, sphingosine-1-phosphate (S1P) and its precursors sphingosine and ceramides, have emerged as pleiotropic signaling molecules that regulate diverse cellular responses. This proposal on the elucidation of novel roles of sphingolipid metabolites in regulation of membrane contact sites, the areas where membranes from two organelles are found in close apposition, will lead to better understanding of how cellular organelles communicate and integrate their activities.